Frederick Animal Health Vet-LIRN Network Capacity Building Project

Abstract: The focus of this proposal is to seek funding for the Frederick Animal Health Laboratory (FAHL) to expand the capability to support the mission of Vet-LIRN (Veterinary Laboratory Investigation and Response Network), though the addition of a Sensititre Vizion Digital MIC Viewing System with Nephelometer for determining bacterial sensitivities of submitted samples. This equipment will allow FAHL to participate in the Vet-LIRN Whole Genome Sequencing project by providing multidrug resistant bacterial strains. FAHL is an ISO 17025 Accredited diagnostic laboratory and is part of the Maryland Department of Agriculture. FAHL has the staff, equipment, technology, and management system to be able to provide critical resources that will benefit and support Vet-LIRN.

Public health relevance
Project Narrative: Recent years have seen an increase in the threats to the food safety and security of both human and animal food supplies. In the proposed cooperative agreement Frederick Animal Health Laboratory will partner with the Veterinary Laboratory Investigation and Response Network (Vet- LIRN) to provide increased resources for the investigation of and response to animal food related illnesses through the addition of a Sensititre Vizion System with Nephelometer. The Sensititre Vizion system would increase the analysis of bacterial sensitivities of the microbiology section in response to Vet-LIRN case investigation from both internal Necropsy and direct sample submissions. This equipment will also allow FAHL to participate in the Vet-LIRN Whole Genome Sequencing project by providing multidrug resistant bacterial strains.